Identifying Relations between Premature Birth, Parental Factors, and the Neural Basis of Numerical Development

Project Summary
Over 10% of infants are born preterm (gestational age < 37 weeks), and these rates are on the rise.
Preterm-born (PTB) children face an increased risk of academic difficulties compared to Term peers, with
specific and persistent difficulties in mathematical development. Success in math is consequential – higher
math skill predicts greater school success, wealth, health, and life satisfaction. Despite their prevalence and
importance, however, the underlying mechanisms of math difficulties in PTB children remain poorly
understood. The goal of this project is to pinpoint the mechanisms that underlie mathematical difficulties in PTB
children during the transition to formal schooling. Our central hypothesis is that early mathematical difficulties
arise from cascading effects of prematurity on foundational verbal skills that affect specialization of critical
neural systems and in turn lead to difficulties in numerical performance, and that these difficulties can be offset
by an enriched home environment. The rationale is that better understanding of the mechanisms of PTB
children’s math difficulties will improve early identification and intervention efforts, ultimately improving
academic outcomes and decreasing societal financial burdens. The central hypothesis will be tested by
pursuing two specific aims: 1) Test a serial mediation model that links gestational age to numerical skill through
verbal skills and neural systems, and 2) Determine the role of the home verbal environment as a moderator of
the link between prematurity and numerical skills. These aims will be pursued through an accelerated
longitudinal study of 240 children from diverse backgrounds across the full spectrum of gestational age (23-41
weeks gestational age at birth). We will administer standardized and lab-based measures to assess numerical,
verbal, and spatial skills throughout the pivotal transition to formal schooling (pre-K to 1st grade). We will
measure brain activity during numerical processing using functional near-infrared spectroscopy (fNIRS). We
will assess home environment via parent-child lab observations and questionnaires. Key covariates, including
pregnancy factors (e.g., birth complications) and child characteristics (e.g., medical morbidities, sex, executive
function) will be considered. The proposed research is innovative, in the applicant’s opinion, because it
represents a substantive departure from the status quo by integrating multiple levels of analysis
(environmental, behavioral and neural), leveraging a wide range of neuroimaging, behavioral, and
observational measures, assessing a broad spectrum of early numerical skills during the significant transition
to formal schooling, and incorporating the full spectrum of gestational age. The proposal is significant as it will
provide the conceptual foundation for much-needed and effective early prevention and intervention efforts that
leverage neural markers and home support to prevent mathematical difficulties in at-risk PTB children and
thereby maximize their future potential.

Public health relevance
Project Narrative The proposed project is relevant to public health because rates of preterm birth (gestational age < 37 weeks) are increasing, and children with preterm birth are at significant risk for math difficulties that significantly diminish their education, wealth, and health outcomes. This proposal will characterize mechanisms of mathematical difficulties during the significant transition to formal schooling and pinpoint cognitive, neural, and environmental factors that predict the variability in children’s early numerical development across the full spectrum of gestational age. The project is relevant to NIH’s mission because it will characterize the roots of mathematical difficulties, pinpoint cognitive and neural markers that might aid early identification efforts, and identify modifiable, person-focused targets for intervention efforts, like home support, that can be leveraged before significant academic difficulties emerge.